Advanced Imaging Tools to Assess Cancer Therapeutics in Pediatric

Advanced Imaging Tools to Assess Cancer Therapeutics in Pediatric Patients
Imaging tests are essential for cancer diagnoses in children. However, computed tomography (CT) and
positron emission tomography (PET)/CT are associated with considerable radiation exposure. Several large
population studies have demonstrated that cumulative radiation doses from CT scans significantly increase the
risk of children developing leukemia, thyroid cancer, and brain cancer later in life. Thus, there is an urgent
need to reduce the radiation exposure of children caused by medical imaging procedures. To this end, we
have developed a radiation-free imaging test for pediatric tumor staging, based on advanced whole body
diffusion-weighted magnetic resonance imaging (WB-DW MRI) technology. Our team was the first to integrate
tumor physiology information (proton diffusion) with an MRI technique for anatomical orientation (nanoparticle-
enhanced T1-weighted MRI), based on the concept of integrated PET/CT scans (Lancet Oncology). While DW
MRI has demonstrated high sensitivity and specificity for cancer detection, the value of DW MRI for cancer
therapy monitoring in children has not yet been extensively studied. Current approaches for assessing tumor
therapy responses in children often measure changes in tumor metabolism using PET after the injection of
radioactive glucose (18F-FDG). Previous comparisons of WB-DW MRI and 18F-FDG PET for cancer therapy
monitoring have been inconclusive, possibly because the scans were not obtained at the same time. Thus,
apparent differences may be due to differences in the timing of the scan. We are in a unique position to
address this problem by simultaneously measuring therapy-induced changes in tumor metabolism and
diffusion in children. These measurements have only recently become possible due to novel integrated
PET/MRI technology, which is available at our pediatric hospital. The overall goal of our project is to
compare the diagnostic value of DW MRI with that of 18F-FDG PET-based imaging tests for tumor
therapy response assessment in children with cancer. In our pursuit of an improved and immediately
clinically applicable approach for a minimally invasive imaging test, we will first apply artificial intelligence
algorithms to develop ultra-low-dose 18F-FDG PET/MR scans. Next, we will determine the value of ultra-low-
dose 18F-FDG PET and DW-MRI scans for monitoring tumor response to classical chemotherapy: We will
determine which pediatric tumor type should be monitored with 18F-FDG PET only, DW-MRI only or a
combined approach. Finally, we will determine the value of ultra-low-dose 18F-FDG PET and advanced DW-
MRI techniques for monitoring tumor response to immunotherapies. Both radiation-free WB-DW MRI and ultra-
low-dose 18F-FDG PET/MRI entail significantly less radiation exposure than traditional 18F-FDG PET/CT scans.
The results of this project will yield customized cancer therapy response assessments for children
with substantially reduced radiation exposure compared with current clinical imaging tests, thus
eliminating associated risks of secondary cancer development later in life.

Public health relevance
PROJECT NARRATIVE Our project aims to develop child-tailored quantitative imaging tools for assessing treatment effects in children with cancer while ensuring the lowest possible radiation exposure. We are testing novel diffusion-weighted magnetic resonance imaging and positron emission tomography technologies for therapy response assessment of pediatric cancers. We anticipate that child-tailored imaging tests will introduce a new, safer, more efficient, and more accurate generation of imaging exams for children that can be widely applied to interrogate health and disease without the risk of radiation-induced secondary cancers later in life.